Including Adults with Intellectual Disability in Precision Medicine Research - Project ENGAGE

Adults with intellectual disability (ID) experience significant negative health outcomes and may benefit from
advances in precision medicine research (PMR) but are often excluded from research. Key reasons for this
outcome are common presumptions about incompetency to consent and questions about the appropriateness
of proxy consent. In the Parent R01, Project ENGAGE, we address these challenges by creating The
ENGAGE Toolkit, an empirically-based, ID-tailored, PMR study-adaptable consent toolkit comprised of legal,
educational, and practical tools to support the inclusion of adults with ID in PMR. Yet, we identified through this
work an additional key barrier: how to practically, fairly, and accurately screen for consent capacity among
adults with ID. Despite evidence that most adults with ID have consent capacity and NIH’s guidance that those
with questionable capacity should be individually assessed, adults with ID are often presumed to lack consent
capacity for research decisions. Additionally, existing consent capacity tools are not appropriate for adults with
ID—a resource gap that may also partially explain why standardized consent capacity evaluations are rare.
Evidence shows that tools may not transfer across populations and that tools without tailoring to the study
population are likely to result in inaccurate evaluations. Adults with ID are thus at risk that they will be
determined to lack capacity, regardless of ability, or to have capacity when they do not. Both options
undermine autonomy, consent and protection of research participants—contrary to foundational principles in
bioethics and research, including PMR. Tailored consent capacity tools that are practical and cognitively
accessible for adults with ID can enhance the culture of responsible inclusion in PMR and remove a
barrier to research that might offer direct benefit to adults with ID. They can minimize inaccurate
conclusions, preserve first person consent, reduce unneeded proxy consent, and in the long run, enhance
representativeness in cohorts, increase generalizability of PMR findings, and promote more applicability of
emerging knowledge from PMR to adults with ID. Yet, no validated ID-tailored consent capacity screening
tool currently exists. The proposed bioethics research study leverages our academic-community partnership
to close this gap by: (1) Adapting an ID-tailored cognitively accessible brief and easy-to-administer consent
capacity screening tool for adults with ID; and 2) Validating the ID-tailored tool by establishing its a) content
validity via cognitive interviews with adults with ID and subject matter expert review, and b) psychometric
properties via its administration with 100 adults with ID and studying its reliability and validity. The ID-tailored
consent capacity screening tool will be added to the web-based Parent R01’s ENGAGE Toolkit for PMR, and
available for use in an array of clinical studies. We will disseminate findings through workshops, webinars,
peer-reviewed publications, and professional presentations. This work will, over time, generate real-world
knowledge for biomedical research while promoting health.

Public health relevance
Adults with intellectual disability experience significant negative health outcomes and may benefit from precision medicine research advances but are often not included in research. Presumed consent incapacity is a major barrier to their inclusion and can be avoided via a validated, disability-accessible tool to accurately screen for consent capacity in this population—but such a tool does not currently exist. A community-engaged approach to adapting and validating a brief, disability-accessible consent capacity screening tool will respond to: (1) expressed needs of precision medicine researchers for practical tools; (2) scientific interest in engaging adults with intellectual disability in precision medicine research; and (3) the goal of promoting health through inclusive precision medicine research.